Mutational signature analysis: methods and applications to the clinic

PROJECT SUMMARY
Mutational signature analysis is a recent analytical approach for interpreting somatic mutations in the genome.
It utilizes the sequence context of point mutations as well as the size and type of copy number and structural
aberrations to decompose the observed mutational patterns into distinct 'signatures', some of which have been
associated with speciﬁc biological processes. In this project, we will develop more robust and sensitive com-
putational methods for mutational signature analysis and apply them to several clinically important questions.
Our initial work has attracted a great deal of attention from clinicians, and we will analyze data from several
clinical cohorts in close collaboration. In Aim 1, we will build upon our previous work to devise a method
that can identify homologous recombination deﬁciency in cancer patients proﬁled on gene panels. Although
whole-genome sequencing offers several advantages, gene panel sequencing remains as a pivotal platform in
clinical care. Our method will enable signature analysis for gene panels from which only a small number of
mutations can be observed. We will incorporate additional sources of information and identify biomarkers for
patient stratiﬁcation. In Aim 2, we will investigate other types of genomic instability such as mismatch repair
deﬁciency, replication stress, and APOBEC mutagenesis. For example, although patients with mismatch repair
deﬁciency generally respond better to immunotherapy, there is a considerable variation across patients. We
will use mutational signatures to identify a subset of patients that respond better. In Aim 3, we will extend our
method to data from circulating tumor DNA and single cell RNA sequencing to enable signature-based predictive
modelling. In Aim 4, we will develop a generalized analytical framework for whole-genome and whole-exome
signature analysis that will overcome the shortcomings of current approaches. We will use this new framework to
build a high-quality reference catalog for the community.

Public health relevance
PROJECT NARRATIVE Identiﬁcation of patterns in DNA mutation data can reveal the biological mechanisms that may be responsible for the alterations. We will develop computational methods to perform such analysis in DNA sequencing platforms used in the clinic. The tools we develop will aid clinicians in therapy selection in cancer and other diseases.